MOLECULAR GENETIC STUDIES ON ALCOHOLISM IN AMERICAN INDIANS

To identify alcoholism risk genes, we are collecting and testing for linkage and pattern of genetic transmission families from three different American Indian populations which are relatively homogeneous and in which alcoholism is highly prevalent. This study also addresses the genetic epidemiology and psychiatry comorbidity of alcoholism in American Indians using structured psychiatric diagnostic interviews of subjects in large families. Data sets of Cheyenne Indian and Pima Indian subjects from large families have been collected. A large panel of random polymorphic probes is being typed in Pima Indian and Cheyenne Indian alcoholics and controls and genetic linkage and transmission analyses are in progress for these groups. An analysis of psychiatric comorbidity in Pima Indian alcoholics and nonalcoholics has been completed.